Integrative and Quantitative Biosciences Accelerated Training Environment

The InQuBATE T32 at the Georgia Institute of Technology will support the integrated training of interdisciplinary Ph.D. students advancing the integrative study of living systems enabled by high- dimensional data analytics and computational models. Student-driven discoveries will broaden the knowledge-base of living systems to address foundational challenges of biomedical relevance spanning molecules, cells, to populations (whether in biofilms amongst population of microbes or between eukaryotic cellular assemblages from tumor microenvironments to cardiac tissue). T32 trainees and affiliates will learn to reason quantitatively about living systems given uncertainty, implement rigorous data analytic principles and algorithms as computational software, extract information and insights from high-dimensional bioscience data sets, and communicate the relevance of their findings to advancing basic research and industrial applications. The translation of core discoveries into industrial and translation applications will be facilitated by industry engagement events where trainees will acquire practical management and leadership skills, applied data analytics training, and will expand their professional networks via direct interactions with industry leaders via multiple industry partners. Overall, the InQuBATE T32 will transform the core set of competencies of Ph.D. students across the spectrum of bioscience, bioengineering, and data science disciplines. In doing so, the T32 program will integrate best practices from bioscience, computing, and engineering disciplines, train the next generation of biomedical scientists to harness the data revolution, and enable trainees to initiate dynamic careers aimed at understanding the structure and dynamics of living systems and their impacts on human health and well-being.

Public health relevance
The InQuBATE T32 at the Georgia Institute of Technology will train PhD candidates spanning the biosciences, engineering, and computing to integrate computational models, data analytics, and the experimental study of molecules, cells, and populations. By fostering a quantitative and data-driven mindset, the T32 will train the next generation of thought leaders to identify principles underlying transitions between health and disease in complex living systems spanning microbial communities, developmental pathways, tumor microenvironments and the dynamics of tissue. Overall, InQuBATE will help transform the foundational and applied study of computational- and data-intensive biosciences in the 21st century and prepare trainees for impactful careers across academia and industry.